Zeiss LSM 980 NLO Confocal Microscope with Airyscan2 for UCI Optical Biology Core

Project Summary/Abstract
The Optical Biology Core (OBC) at the University of California, Irvine (UC Irvine) requests a Shared
Instrumentation Grant to purchase a Zeiss LSM 980 Non-Linear Optics (NLO) confocal with Airyscan 2 FLIM
ready. The LSM 980 will bring new capabilities such as higher resolution, more rapid data acquisition and AI-
based sample finding that are not currently available to users. Importantly, the LSM 980 will replace a current
microscope that is very heavily used and is over 10 years old and thus no longer eligible for service contract
coverage after October 2022. The existing LSM 780 NLO confocal microscope has been used on average over
270 hours per month for the past 12 months, excluding the 3-month pandemic shutdown, with current usage
close to 80 hours per week. This flagship instrument has been a critical component for researchers in over 34
labs across campus, and replacing it is essential to maintaining the highest level of instrument functionality,
dependability, and availability across this wide disciplinary range.
The LSM 980 will be located in dedicated space within the OBC. The OBC will provide administrative and
technical support to maintain the microscope as well as advice on experimental set up, training and imaging,
and data analysis expertise to enable users to take full advantage of its capabilities. The OBC has operated at
UC Irvine since 1987 demonstrating its stability, capability and a long-standing institutional commitment to
microscopy and imaging resources. The OBC receives robust financial commitments towards instrument service
contracts, staff salaries and microscope accessories from a broad array of institutional sectors including the
Office of Research, the NCI-funded Chao Family Comprehensive Cancer Center and four individual Schools:
Biological Sciences, Engineering, Medicine, and Physical Sciences.
Replacement of the existing LSM 780 will bring significantly improved imaging capabilities. The LSM 980
incorporates the Airyscan detector (first introduced in 2014), which samples high spatial frequencies with an end
result of a two-fold improvement in resolution (120 nm and axial resolution of 350 nm) and up to an eight-fold
improvement in signal to noise. Additional design and engineering improvements in the LSM 980 permit a larger
field of view and much faster scanning than is possible with the LSM 780 while continuing to support two-photon
and Fluorescence Lifetime Imaging (FLIM). These improved capabilities will enhance research currently using
the LSM 780 by providing higher-resolution images in less time. Specific benefits to human health from projects
of the major users include gaining a better understanding of: (1) how new drug therapies for cancer and other
diseases can be enhanced; (2) delivery of synthetic vectors to cells; (3) how macrophages behave in response
to natural and synthetic biopolymers; (4) antibiotic development; (5) tissue and nerve regeneration; (6) wound
repair; and (7) how synaptic structures in the human brain are affected by behaviors, aging, and memory.

Public health relevance
Project Narrative The Optical Biology Core (OBC), an optical microscopy shared-resource facility at UC Irvine, requests a next- generation confocal microscope to support health-related research funded by the NIH in diverse areas including cancer biology and wound healing. The new microscope will replace an existing confocal purchased 11 years ago that is still being heavily used (on average more than 270 hours/month) but is rapidly approaching obsolescence. The new microscope's enhanced features such as improved resolution, sensitivity, signal-to- noise, rapid detection and AI driven image acquisition will provide a critical upgrade to research efforts and the development of student skills in Cell Biology, Medicine, Biomedical Engineering, and Chemistry in over 34 labs on the UC Irvine campus.